EUS Diagnosis of Chronic Pancreatitis

DESCRIPTION (provided by applicant): The overall goals of the proposed application are: (1) to prepare the principal investigator for an independent career in patient-oriented clinical research and (2) to definitively establish and validate baseline endoscopic ultrasound (EUS) test characteristics used for the diagnosis of chronic pancreatitis (CP). Dr. Gardner hypothesizes that cataloguing and standardizing EUS abnormalities will improve interoperative agreement and therefore enable a higher degree of diagnostic accuracy for CP. Dr. Gardner completed an advanced fellowship in clinical pancreatology at the Mayo Clinic in Rochester, MN where he refined his skills in EUS and cemented his interest in caring for patients with CP. He is currently the Director of Pancreatic Disorders at Dartmouth-Hitchcock Medical Center where he performs 500 EUS examinations yearly and has completed several preliminary studies evaluating the role of EUS in diagnosing early CP. This award should provide the framework for Dr. Gardner to pursue his long-term goal of establishing and validating a novel, evidence-based diagnostic criteria for CP through an R01 or equivalent. During the grant period he will take coursework in clinical research and biostatistics leading to a Masters of Science degree at the Dartmouth Institute. He has enlisted the support of world-renowned clinician/researchers to support his career development and the research proposal. For this project, he will survey expert endosonographers, conduct a videoclip interpretation study and perform tandem EUS examinations to learn which morphologic features are most relevant to endosonographers when diagnosing CP and the inter- and intra-rater reliability of each morphologic EUS feature between endosonographers. Additionally, he will perform EUS exams on patients with and without pancreatic disease to learn which features are present in normal patients and whether any alterations occur with aging and the influence of body mass index, clinical symptoms, health habits, and comorbidity on EUS features. Finally Dr. Gardner will perform combined secretin-enhanced EUS in patients with suspected CP to learn the duodenal bicarbonate concentration in subjects with and without pancreatic disease. This study should lead to better consensus among endosonographers, more appropriate classification of EUS abnormalities in the normal and diseased pancreas, and validation of secretin EUS as a practical and useful tool for the diagnosis of CP.

Public health relevance
PUBLIC HEALTH RELEVANCE: As it is increasingly apparent that early stage chronic pancreatitis needs to be diagnosed appropriately so that disease modifying therapies can be initiated, the importance of accurate EUS diagnosis is critical. Cataloguing and standardizing EUS abnormalities will allow physicians to better understand how to interpret this test so that patients can be confidently diagnosed and treated. Project Narrative As it is increasingly apparent that early stage chronic pancreatitis needs to be diagnosed appropriately so that disease modifying therapies can be initiated, the importance of accurate EUS diagnosis is critical. Cataloguing and standardizing EUS abnormalities will allow physicians to better understand how to interpret this test so that patients can be confidently diagnosed and treated. __SpecificAimsTextDelimiter__ Specific Aims Chronic pancreatitis (CP) leads to alteration in pancreatic structure and function, the degree of affliction being dependent on severity of disease. While diagnostic changes on cross sectional imaging (abdominal computerized tomography scan (CT) or magnetic resonance imaging (MRI)) are seen in advanced disease, early in the course of CP these studies are non-diagnostic. Early or "minimal-change" CP may be defined as CP without diagnostic changes on CT or MRI. Endoscopic ultrasound (EUS) has exquisite sensitivity to detect early parenchymal and ductal changes in the pancreas while simultaneously allowing assessment of pancreatic exocrine function. EUS clearly has the potential to be the best test to diagnose early CP. However, EUS remains highly operator-dependent and lack of inter-observer agreement (IOA) on EUS findings and limited acceptance of endoscopic secretin testing remain the biggest hurdles to realizing the full potential of EUS to diagnose CP. Even expert endosonographers differ in their interpretation of EUS findings. We hypothesize that cataloguing and standardizing EUS abnormalities will improve IOA and therefore enable a higher degree of diagnostic accuracy. Endoscopic secretin testing is a relatively new test and its performance characteristics in health and disease need further validation. The focus of this career development award is to definitively establish and validate baseline EUS test characteristics used for the diagnosis of CP. This study should lead to better consensus among endosonographers, more appropriate classification of EUS abnormalities in the normal and diseased pancreas, and validation of secretin EUS as a practical and useful tool for the diagnosis of CP. Specific Aim I. To improve the reliability of pancreatic EUS for the diagnosis of CP Hypothesis: The poor inter- and intra-rater reliability between endosonographers and lack of consensus about the relative importance of specific EUS features make the diagnosis of CP variable between examiners. I will survey expert endosonographers, conduct a videoclip interpretation study and perform tandem EUS examinations to determine: 1. Which morphologic features are most relevant to endosonographers when diagnosing CP 2. The inter- and intra-rater reliability of each morphologic EUS feature between endosonographers Specific Aim II. To determine the prevalence and predictors of EUS abnormalities in subjects with and without pancreatic disease Hypothesis: The baseline EUS appearance of the pancreas in "normal" and "diseased" subjects is not truly known because patient characteristics and habits, chronic health conditions and symptoms may influence the morphologic EUS findings. I will perform EUS on patients with and without pancreatic disease to establish: 1. Which features are present in subjects without pancreatic disease 2. The influence of age, body mass index, symptoms, health habits, and comorbidity on EUS features 3. The EUS appearance of patients with definitive and probable CP by standard criteria Specific Aim III. To establish the role of secretin-enhanced EUS to diagnose pancreatic disease Hypothesis: Measurement of duodenal bicarbonate concentration and pancreatic duct caliber change following stimulation of the exocrine pancreas by human secretin can aid in the EUS diagnosis of CP. I will perform combined secretin-enhanced EUS in patients with suspected CP to evaluate: 1. Duodenal bicarbonate concentration in subjects with and without pancreatic disease and correlate with severity of EUS abnormalities as noted in specific aim 1. This will, for the first time, provide normal values for bicarbonate concentrations based on co-factors that influence EUS appearance. 2. The change in duct diameter measured in the head, body and tail following secretin stimulation. This change will be correlated with EUS abnormalities in health and disease.